Multimodal dissociation of posterior cingulate cortex contributions to episodic memory

Project Summary
Episodic memory is the ability to recall details about prior experiences. Researchers have historically relied on
controlled item-recognition paradigms, in complement to autobiographical recall tasks, to investigate the
biological substrates of episodic memory. Contemporary theories posit that episodic memory is supported by a
constellation of neocortical regions, in concert with the hippocampus and medial temporal cortices. Of these
neocortical regions, the posterior cingulate cortex (PCC) stands out because it is reliably observed in
neuroimaging studies of episodic memory and demonstrates engagement that is sensitive to memory strength.
Although a large literature indicates that the PCC is critical for episodic memory, very little is known about its
unique role in memory or cognition more broadly. Meta-analyses of functional neuroimaging studies that have
investigated the relationship between memory tasks and PCC activations provide some insight as to the region’s
role. Strikingly, while item-recognition tasks are associated with activity in the dorsal subregion of the PCC
(dPCC), autobiographic recall tasks are uniquely associated with activity in the ventral PCC subregion (vPCC).
This functional divide mirrors similar cytoarchitectural and network-connectivity differences found along the
dorsal-ventral axis of the PCC. Furthermore, the dPCC is consistently implicated in decision-making studies,
while the vPCC has been found to be involved in the representation of specific features and semantic
associations of retrieved memories. Synthesizing across previous observations suggests that the dPCC serves
as a putative accumulator of mnemonic evidence during memory-based decisions, while the vPCC serves to
support the retrieval of details about previous episodes. However, progress in clarifying the contributions of PCC
subregions to episodic memory have been stymied due to the location of the region within the medial surface,
making it challenging to isolate the dynamics of PCC signals using traditional electrophysiological recording and
neuroimaging methods. The use of cutting-edge techniques can help overcome previous limitations in
spatiotemporal precision that have prevented advances in understanding the function of the PCC: high-resolution
functional neuroimaging and invasive electrophysiological recordings of population and single neuron activity.
An openly-available, high-resolution neuroimaging dataset containing thousands of item-recognition trials per
participant will be used to isolate the functional organization of item-recognition response patterns in the PCC.
Population responses collected via intracranial electrodes will be analyzed in order to temporally isolate tightly
coupled memory-decision and memory-retrieval processes across the PCC. Additionally, single unit recordings
from the PCC will be collected and used to test whether memory-selective and visual-selective units can be
identified in the PCC, underlying population level signals observed in response to memory decisions and
retrieval. Results from this work will provide a significant advance to our understanding of functional organization
in the PCC, helping map the ways memory deficits can progress in healthy aging and disease.

Public health relevance
Project Narrative This project will use high-resolution functional neuroimaging and human intracranial recordings to delineate the contributions of the dorsal and ventral subregions of the posterior cingulate cortex (PCC) to episodic memory. This research will test the hypothesis that the dorsal PCC serves as a putative accumulator of mnemonic information in support of memory-based decisions, while the ventral PCC supports the retrieval of mnemonic details and associations from previous episodes. Abnormalities in the function and structure of the PCC are associated with neurodegenerative diseases (e.g. Alzheimer’s disease), and further understanding of the precise functional organization of the PCC will help to both better understand cognitive deficits that characterize disease progression and to inform more precise interventions aimed at mitigating these deficits.